Project 3 - Development and Field Application of Novel Ultrasensitive Devices for the Measurement of Airborne VOCs

PROJECT SUMMARY (Project 3)
This proposed work is to advance airborne volatile organic compound (VOC) detection and quantification
technologies, and to robustly characterize indoor/outdoor contrast and in-home determinants for exposures to
target Superfund-relevant VOCs. This research will continue to grow and expand two VOC real-time in situ
measurement platforms developed by the University of Louisville Superfund Research Center established in
2017. One platform comprises small, low-cost sensors that can be deployed alone or in networks. Novel gas
sensors and sensor arrays are being developed to measure target Superfund-relevant VOCs including acrolein,
trichloroethene (TCE), benzene, toluene, ethylbenzene, and xylene (BTEX). The devices use novel surface
chemistries to address the common challenges of selectivity and sensitivity and are fabricated using
microelectromechanical systems (MEMS) technology. Another platform addresses the need for flexibly
designed, field-deployable instruments that can measure with high sensitivity a large range of compounds to
interrogate microenvironments with complex VOC mixtures. The Multichannel Organics In-situ enviRonmental
Analyzer (MOIRA) instrument, developed in the first cycle of Center funding for mobile monitoring, will be
expanded and optimized for indoor/outdoor VOC monitoring studies. MOIRA is a gas chromatography–mass
spectrometry (GC-MS) instrument with high time resolution (e.g., ten minutes). Its capabilities will be expanded
to measure both higher and lower volatility compounds than can be achieved with the current design. These
innovative, high time resolution in situ measurements will be coupled with conventional time-integrated VOC
passive sampling to measure target Superfund-relevant VOCs at homes of some participants in the allied clinical
study. These data will be used to build spatiotemporal models to estimate ambient VOCs at the homes of all
clinical study participants, and to gain new insights into VOC levels and their determinants in the home
microenvironment. In addition to exposure assessment, the two measurement platforms are responsive to
ongoing Superfund program advancements; these innovative developments will expand future capacities to
monitor VOC indoor vapor intrusion, monitor outdoor VOC levels during site remediation, and monitor both
indoors and outdoors during post-remediation surveillance.

Public health relevance
RELEVANCE This proposed work is to support continued research within the University of Louisville Superfund Research Center on novel technologies to detect and quantify Superfund-relevant volatile organic compounds (VOCs) in air. These technology platforms will be used to better understand VOC sources and human exposures.